A Randomized Study of Maternal Donor Derived CMV Cytotoxic T-Lymphocytes (CTLs) and Valganciclovir vs Valganciclovir in Neonates With Moderate/Severe Maternal Acquired CMV Infection

Project Summary
Congenital cytomegalovirus (cCMV) infection that is acquired in-utero, although an orphan disease (20-80,000
cases/yr in U.S.) is the most common congenital infection in the U.S. and the leading cause of long-term
neurodevelopmental disabilities. cCMV infection represents 41% of all CMV associated childhood deaths. This
high degree of morbidity and mortality is in large part secondary to the large CMV genome whose genes are
designed to facilitate evasion, blocking, impairing and modulation of host anti-viral immune responses and an
immaturity and deficit in neonatal T-cell adaptive immunity at birth. This maladaptive T-cell immune response at
birth results from temporal and developmental immune dysregulation in-utero with a resulting bias towards
tolerance and preventing maternal immunological rejection, thereby suppressing normal T-cell maturation and
development of memory T-cells to foreign microbial antigens. Importantly, a poor CMV specific T-cell adaptive
immune response predisposes neonates with cCMV acquired in-utero to a significant increased risk of serious
long-term morbidity and increased mortality. Restoring, at least temporarily, both CD4 and CD8 specific CMV T-
cell mediated immunity in neonates with maternal acquired cCMV is therefore critical to eradicating persistent,
refractory and/or resistant CMV infection and undesirable long-term sequelae and represents an unmet need.
We have previously established a Viral Cytotoxic T-Cell Lymphocyte Consortium (VIRCTLC) funded under an
FDA Orphan Grant to manufacture under GMP conditions and enrich for haploidentical (maternal) donor-derived
CMV specific CTLs utilizing a CMV specific Peptivator® and the cytokine Capture System (CCS®) on the Miltenyi
CliniMACS® device for treatment of infants and children with refractory/persistent CMV infection with primary or
secondary T-cell deficiencies. We, therefore, hypothesize that manufacturing maternal donor-derived CMV CTLs
and subsequent administration in neonates with maternal acquired cCMV will be feasible and safe and effective
in combination with standard of care (SOC) (valganciclovir [valGCV]) compared to those treated with SOC alone.
The three overarching aims of this FDA orphan grant proposal includes: 1) To determine feasibility, safety and
compare the efficacy of maternal donor-derived CMV specific CTLs with SOC vs SOC alone; 2) To characterize
the genomic and immunomic signatures and persistence of maternal donor-derived CMV CTLs and comparison
of innate and adaptive immune landscape post CMV CTL administration; and 3) To quantify the severity and
incidence of long-term neurological sequelae and developmental disabilities between the two treatment groups.
CMV CTLs will be manufactured under GMP conditions utilizing the CCS® and administered every 2 weeks up
to 5 doses with valGCV x 6 months or valGCV alone. Genomic and immunomic studies will be performed by
ScRNAseq, mass cytometry, high dimensional flow cytometry and Nanostring immunoprofiling. Long-term
neurological sequelae will be measured by audiograms, brain MRIs, developmental testing, among others.

Public health relevance
Project Narrative Due to specific properties of cytomegalovirus (CMV) and an immature immune system at birth, newborns are highly prone to acquire CMV infection from their mother and thereby are predisposed to serious CMV related complications both at birth and long-term neurological and developmental disabilities. We have previously developed a method of isolating and enriching CMV specific memory immune cells from mothers and have successfully administered these cells to their infants and children with refractory CMV infection who have weak immune systems. We propose in this grant to investigate the safety and effectiveness of maternal derived CMV memory immune cells in combination with standard antibiotics vs antibiotics alone in the treatment of neonates with CMV infection at birth.